IGF::OT::IGF Synthetic Peptides and Other Drugs of Abuse; Purity Determination, Stability Testing and Quantitative Analysis. NIDA Ref. No. N01DA-18-8945; POP: 09/29/2018 - 09/28/2019. Base Award

Specifically, NIDA through this contract plans to (1) analyze and establish the purity of peptides that are
synthesized through NIDA contracts, (2) regularly monitor the purity and stability of these peptides, and
(3) develop methods and analyze various drugs of abuse and other probes available in the drug supply
inventory for purity and authenticity verification as needed.